Cortical Localization in Epilepsy

Project Summary/Abstract
The ability to produce the correct words while speaking is critical for normal social, academic and occupational
functioning. Unfortunately, for many children with uncontrolled epilepsy, surgical treatment for seizure control
can place these vital language skills at risk. Extensive research in adults with refractory epilepsy has shown
significant risk to word production or “naming” ability that can be predicted before surgery based on clinical
factors and, in some cases, prevented using preoperative language mapping. In marked contrast, we are
currently unable to predict risk to expressive language in children, and the mapping techniques currently
utilized have failed to reliably identify and protect language cortex in children. This represents a serious gap in
clinical care, as prediction and protection of language are critical during development. A key problem has been
the approach to naming in children, both in behavioral assessment and in preoperative language mapping.
Significant advances in the neuroscience of naming have shown that traditional methods, which rely solely on
visual object naming without regard to speed of response and other cognitive features of naming, can miss true
naming deficits in assessment, and fail to identify essential naming areas in cortical language mapping. In
adults, the addition of auditory description naming to preoperative assessment has assisted in lateralization of
dysfunction related to epileptogenic cortex, and has improved mapping efficacy by identifying critical language
cortex that otherwise remained undetected. We recently developed pediatric auditory naming and
complementary visual naming measures that showed significant sensitivity to lateralized epilepsy-related
dysfunction in preoperative children with refractory epilepsy. These measures now enable accurate and
detailed assessment of naming in children. This project will use these recently developed tests, pre and
postoperatively, and in cortical language mapping to: 1) identify the factors that predict both short- and long-
term postoperative decline, 2) determine when decline is global or limited to one modality, and 3) determine
whether modality-based naming can more effectively identify and protect language cortex in children. Results
promise empirically based knowledge of risk to postoperative verbal skills in children with refractory epilepsy,
improved language mapping in children, and advances in the cognitive neuroscience of language development
and recovery. With increasing numbers of children undergoing epilepsy surgery, we can expect a growing
need for accurate prediction, protection and measurement of pediatric language outcome.

Public health relevance
Project Narrative Word finding or “naming” decline is a risk of surgical treatment for seizures that are not controlled by medication. Although research has provided methods to help predict and sometimes protect naming abilities in adults, we are unable to provide these same benefits to children with epilepsy. This work aims to determine how to predict and ultimately protect word production skills in children who undergo epilepsy surgery.